Mechanisms of regulatory T cell-mediated recovery from severe viral pneumonia

PROJECT SUMMARY/ABSTRACT
Severe viral pneumonia due to influenza A virus and SARS-CoV-2 injures the lung to cause the acute respiratory
distress syndrome (ARDS). Viral pneumonia-induced ARDS carries a mortality rate approaching 40% despite
advances in clinical management, with unrepaired lung injury placing patients at risk for fatal intensive care unit
(ICU) complications. Therefore, we reason that activation of lung repair following severe viral pneumonia will
spur the process of recovery to reduce the duration of time that patients require the ICU, mitigating the ICU’s
attendant morbidity and mortality. CD4+FOXP3+ regulatory T (Treg) cells are required for healthy repair of lung
injury in mouse models of viral pneumonia and accumulate in the alveolar spaces of patients with severe
pneumonia and ARDS. Within Treg cells, the DNA methylation pattern at specific genomic loci as well as
mitochondrial metabolism determine their identity and function. Alveolar Treg cells in patients with severe
pneumonia display DNA methylation and transcriptional profiles predicted by mouse experiments, credentialing
Treg cells as a cellular therapy if several barriers are surmounted. Specifically, 1) metabolic challenges to Treg
cell function hinder clinical Treg cell transfer protocols, and 2) induced (i)Treg cells, which derive from abundant
conventional T cells following treatment with TGF-β ex vivo, exhibit transcriptional and functional instability in
inflamed microenvironments, limiting their use as a cellular therapy. Preliminary data suggest that an energy-
sensitive enzyme, AMPK, regulates DNA methylation to promote Treg cell lung-protective function in vivo and
that a DNA methylation maintainer, UHRF1, stabilizes iTreg cell identity after adoptive transfer to mice with
influenza A virus pneumonia. Accordingly, we hypothesize that AMPK optimizes Treg cell pro-repair function
in the virus-injured lung and UHRF1 stabilizes iTreg cell pro-repair function to drive recovery from viral
pneumonia. In our three Specific Aims, we will use innovative and rigorous approaches, including Treg cell-
specific inducible systems in mice and a case-control study of patients with severe viral pneumonia. In Aim 1,
we will determine whether AMPK is necessary to promote DNA methylation patterns that optimize mitochondrial
and pro-repair function in Treg cells during recovery from influenza A virus pneumonia. In Aim 2, we will
determine the necessity of UHRF1-mediated DNA methylation in stabilizing iTreg cell transcriptional programs
and pro-repair function during recovery from influenza A virus pneumonia. In Aim 3, we will determine whether
AMPK-associated transcriptional programs and the DNA methylation status of mitochondrial metabolism-
promoting genes are correlated with 30-day mortality in alveolar Treg cells obtained from patients with severe
viral pneumonia. Our proposal will establish causal evidence linking targetable mechanisms to detailed
physiological readouts of Treg cell function. Elucidating these causal links will inform the development of Treg
cell-based therapeutic approaches for patients with severe viral pneumonia and other causes of ARDS.

Public health relevance
PROJECT NARRATIVE Influenza virus (the flu) and SARS-CoV-2 (COVID-19) cause lung injury and are associated with hundreds of thousands of respiratory deaths due to severe viral pneumonia per year worldwide even in non-pandemic years. A specialized subset of T cells known as regulatory T cells promotes recovery from severe viral pneumonia, but the injured lung poses challenges to regulatory T cell pro-recovery function. By studying how epigenetic and metabolic pathways control the regulatory T cell response to viral lung injury in mice and humans, we will ascertain fundamental mechanisms that optimize regulatory T cell pro-recovery function, thus informing the development of regulatory T cell-based therapies for patients with severe viral pneumonia.